Targeting circRNA translation in glioblastoma

Project Summary
Glioblastomas are highly malignant and invasive, making these neoplasms extremely difficult to surgically
resect and these properties often result in tumors which are refractory to standard chemotherapeutic therapies.
Unfortunately monotherapies targeting known drivers of glioblastomas such as hyperactive EGFR and c-MET
RTKs have proven to be ineffective suggesting redundant mechanisms of activation. We have identified
circular RNA-derived proteins which are overexpressed in glioblastoma and these novel products are capable
of stimulating receptor tyrosine kinase activity leading to enhanced proliferation, mobility and invasive
characteristics. In this application we propose to 1.) determine the mechanism(s) of circ-HGF mediated
activation of c-MET in glioblastoma, 2.) clarify the role of PKA/PTBP1 signaling in the regulation of circ-HGF
and circ-E-Cad translation initiation and expression in GBM, 3.) evaluate a novel small molecule inhibitor of
circ-HGF and circ-E-Cad IRES-dependent translation in orthotopic GBM PDX models. We also propose to
investigate and chemically modify the inhibitor to build in desired anti-glioblastoma effects.

Public health relevance
Project Narrative Successful completion of this project will substantiate a preclinical rationale for targeting circular RNA-derived proteins which activate known drivers of glioblastoma for trials in patients. Additionally, this study will provide information as to the operative mechanisms resulting in hyperactive receptor tyrosine kinase signaling leading to escape from current targeted therapies for glioblastoma management.